The role of host amino acid metabolism in behavioral changes during latent toxoplasmosis

Toxoplasmosis is an opportunistic disease caused by the obligate intracellular parasite Toxoplasma gondii. This
parasite has been infected nearly 2 billion people globally. In healthy individuals, Toxoplasma infection is usually
asymptomatic or it presents as mild flu-like symptoms, as the immune system effectively keeps the replicative
forms (tachyzoites) from causing illness. However, by converting into latent forms, Toxoplasma forms tissue
cysts in the brain and heart that persist for a lifetime. Toxoplasma tissue cysts are surrounded by a thick wall
which protects the parasites to available drugs and host immune response. Bradyzoites, the latent forms found
in tissue cysts, sense the environment and can be released from the cysts and transformed into tachyzoites,
which results in reactivation of the disease. This frequently occurs in HIV/AIDS patients, and it causes brain
lesions that can be life-threatening. In healthy individuals, there is a correlation between chronic toxoplasmosis
and neurocognitive impairment, as well as mental and neurological disorders. We previously demonstrated that
neuroinflammation is one of the major factors that contribute to behavioral changes in Toxoplasma-infected mice;
this was recently confirmed by another study that found that several amino acid related genes are dysregulated
in the brains of infected mice, contributing to behavioral alterations and neuroinflammation. Auxotrophic for
several nutrients Toxoplasma acquires amino acids from the host to establish infection, which affects the host
cell metabolism and amino acid availability. We recently demonstrated that Toxoplasma depletes arginine in
infected cells leading to host metabolic changes resulting in higher expression of host cationic amino acid
transporter-1 (CAT1) regulated by GCN2. Toxoplasma infection induces not only CAT1 expression but also
increases the arginine transporter activity, elevating the arginine levels of infected cells. While we have made
progress in understanding the role of arginine during Toxoplasma acute infection, the role of this and other host
amino acid availability during chronic toxoplasmosis has been frustratingly mysterious. Our preliminary findings
support our working hypothesis that Toxoplasma modulates host amino acid pathways to establish chronic
infection. This proposal will test the hypothesis that two-host amino acid metabolism pathways, GCN2 and
mTORC1, mediate parasite persistence in the brain. Our experimental plan consists of two independent aims
that will elucidate the role of amino acid metabolism during Toxoplasma infection in the brain and how amino
acid availability contribute to behavioral changes in chronically infected mice. Aim 1 will determine the role of
host amino acid levels during development of Toxoplasma tissue cysts in mice. Aim 2 will elucidate the role of
GCN2 and mTORC1 pathways in neurological alterations during Toxoplasma infection. Resolving the
mechanism underlying this observation will provide much needed insight into how the parasite causes
neurological alterations putting us in a better position to develop novel therapies to treat Toxoplasma in patients.